Randomized Comparison of the Clinical Outcome of Single Versus Multiple Arterial Grafts: Cognition (ROMA:Cog)

PROJECT SUMMARY/ABSTRACT
Coronary heart disease affects over 18.2 million Americans and coronary artery bypass surgery (CABG) is the
most common cardiac surgery in adults. Unfortunately, CABG is associated with stroke, cognitive impairment,
and dementia, especially among women and patients with diabetes. As many as 25% of patients with a clinically
uncomplicated postoperative course have evidence of brain emboli after CABG, and even small infarcts can
unmask latent neurodegeneration and increase postoperative cognitive impairment. Intraoperative
thromboembolism is one of the mechanisms contributing to cognitive impairment, due to surgical aortic
manipulation. Less aortic manipulation is associated with less plaque dislodgement, resulting in fewer embolic
events during cardiac surgery. The Randomized comparison of the clinical Outcome of single versus
Multiple Arterial grafts: Cognition (ROMA:Cog) study will identify both the global impact of CABG surgery
and the impact of acute infarction on cognitive function. The first aim addresses the impact of CABG surgical
technique on long-term cognitive function in an international cohort of 2,000 participants who have been
randomized to either a multiple arterial grafts or single arterial grafts groups and by important subgroups including
women and patients with diabetes. Results will either demonstrate differences in cognitive function or provide
reassurance to cardiac surgeons that there are no differences in the proportion of patients with cognitive
impairment by surgical technique. In the second and third aims, the short-term impact of CABG surgical
technique will be determined based on domains of cognitive performance, and the associations among CABG
surgical technique, cognitive performance, brain infarction and novel serum biomarkers of brain health in a cohort
of 280 participants. Results will provide us with mechanistic details on the relationships between surgical
technique, detailed cognitive performance, acute MRI indicated brain infarction, and novel biomarkers of brain
health. Leveraging the international ROMA trial infrastructure, one of the largest cardiac surgery trials to date,
we have an unprecedented opportunity to clarify the impact of CABG surgical technique on short and long-term
cognitive function. Preventing postoperative cognitive impairment is an important public health concern that could
be mitigated with specific surgical techniques. The ROMA:Cog study will help to identify people who could benefit
from detailed cognitive evaluation and early interventions, and will establish whether serum biomarkers can be
used as novel surrogate end-points in future studies to prevent vascular cognitive impairment.

Public health relevance
PROJECT NARRATIVE The primary objective of this study is to reduce cognitive impairment after coronary artery bypass graft (CABG) surgery. Our central hypothesis is that CABG using multiple arterial grafts will be associated with less cognitive impairment than CABG with single arterial grafts, due to less intraoperative aortic manipulation, better patency of arterial compared to saphenous grafts, and lower risk of revascularization. The proposed study will leverage an international cohort determine: 1) the impact of CABG surgical technique on short-term cognitive domain impairments by sex and among patients with diabetes; 2) the impact of surgical technique on multiple cognitive domains in the year after surgery; and 3) the relationships between CABG surgery, brain infarction, novel biomarkers of brain health, and cognitive performance.